Manganese-Related Motor and Cognitive System Toxicity Among Professional Welders.

ABSTRACT
Millions of workers in the US and worldwide, including professional welders, experience prolonged, high-
dose occupational exposures to manganese (Mn). Over-exposure to environmental manganese (Mn) has
long been established as a cause of adverse motor system effects that have clinical features similar to
parkinsonism (PS), which is the most common clinical manifestation of Parkinson disease (PD). There is
also evidence that Mn exposure can induce dysfunction of cognitive control, mood, and behavior. The
primary goal of the proposed investigation is to perform a comprehensive clinical assessment of Mn-related
motor and cognitive system neurotoxicity among a well-characterized cohort of professional welders we
have studied for the past 13 years. Accordingly, we will extend our clinical assessments of motor system
toxicity and conduct a comprehensive battery of cognitive and behavioral tests, and estimate dose-response
relations with Mn exposure. The cognitive/behavioral battery will be a new feature of the study. We will also
test the hypothesis that plasma proteins known to be associated with PD: alpha synuclein (SNCA), protein
dyglycase (DJ1 [PARK7]), and ubiquitin carboxy-terminal esterase (UCHL1), are associated with risk,
severity, and progression of PS in the cohort. The study will be conducted among 500 (of 938) welders who
will be re-enrolled. The proposed study will be the most comprehensive clinical assessment of motor and
cognitive neurologic outcomes in an Mn-exposed cohort conducted to date. An especially novel feature of
the proposed study is characterization of protein biomarker measurements that may serve as preclinical
indicators of subsequent clinically determined parkinsonian outcomes. The findings from this research
should have important implications for setting occupational Mn exposure standards, and may ultimately
inform disease prevention strategies for Mn-related adverse neurological outcomes.

Public health relevance
NARRATIVE Over-exposure to manganese (Mn), as can result from welding fumes, is an established cause of nervous system damage that has features similar to parkinsonism (PS), and cognitive impairment. We propose to characterize risks and severity of these outcomes among Mn-exposed professional welders, and to assess blood protein profiles that may ultimately predict Mn-induced nervous system damage. The findings from this research should ultimately have important implications for neurologic disease prevention among Mn- exposed workers in the US and worldwide.